Role of inflammation in intraplaque hemorrhage pathogenesis

PROJECT SUMMARY
Atherosclerotic cardiovascular disease (ASCVD) remains the leading cause of death in the US. Despite
guidelines promoting aggressive anti-atherosclerotic therapies, there is »5%/year residual ASCVD risk in
patients who achieve profound LDL-C lowering (median 30 mg/dL) with combined statin and PCSK9 inhibitor
therapy. New treatment strategies are needed to target the mechanisms beyond LDL to reduce this residual
risk. Histologic studies have demonstrated that plaque neovasculature constitutes the main entrance for
inflammatory cells into plaques and provides a major source for the formation and progression of intraplaque
hemorrhage (IPH). IPH, mainly resulting from plaque neovascularization, is a common feature of advanced
atherosclerotic lesions and a critical element leading to accelerated plaque progression, plaque instability and
ischemic vascular events in humans. We found that plaque neovessel permeability (measured as Ktrans, using
dynamic contrast enhanced magnetic resonance imaging) is strongly correlated with macrophage content and
that greater adventitial Ktrans is associated with IPH. Recent studies have identified that CD163+ macrophages
are associated with IPH and can further promote neovascularization leading to IPH progression. On the other
hand, B1 cell-derived IgM can inhibit inflammation and reduce atherosclerosis, and circulating human B1 cells
are inversely associated with coronary plaque volume and instability features. Our preliminary data showed
that plasma IgM levels are reduced in patients with carotid IPH and B1 cells are inversely associated with IPH
progression. We, therefore, propose to study the role of B1 cell-derived IgM and B1 cells in IPH pathology.
To test a novel hypothesis that B1 cell-derived IgM levels are reduced in patients with IPH and that
the reduction in protective IgMs results in unobstructed IPH-promoted inflammation and neovessel
permeability, thereby exacerbating plaque progression, we propose to conduct comprehensive studies
including: (1) histological examination of CEA specimens to determine whether plaques with increased Ktrans
and/or IPH have a lower density of IgM and a higher density of CD163+ macrophages; (2) a longitudinal clinical
follow-up study in 250 patients to determine whether lower IgM levels and B1 cells predict progression of Ktrans
and IPH and whether IgM production and effect on macrophages are different in B1 cells in patients with and
without IPH; (3) in vitro mechanistic studies of endothelial sprouting and leakiness using 3D microvessels to
determine the effects of IgM and B1 cells on RBC-induced changes in macrophages and vascular permeability.
This proposal utilizes state-of-the-art imaging technique for quantification of vascular permeability and IPH
and 3D microvessels for study how hemoglobin-stimulated macrophages and B1 cells and/or IgM influence
endothelial function related vascular permeability. Our study will gain new knowledge to uncover inflammatory
mechanisms in IPH pathogenesis and to discover potential therapeutic targets with a goal of reduced vascular
permeability to prevent IPH and its progression, which will ultimately reduce residual ASCVD risk.

Public health relevance
NARRATIVE Heart attacks and strokes remain the leading cause of death in the United States and despite current guidelines on aggressive cholesterol treatment and blood pressure management, some people continue to suffer cardiovascular problems leading to a poor quality of life and high cost of health care. The proposed study will investigate the effects of inflammation on bleeding inside of plaques, called intraplaque hemorrhage, one of the important plaque risk features that can cause heart attacks and strokes. The study will help us to better understand the problem with intraplaque hemorrhage and discover potential new treatments that can further reduce heart attacks and strokes.